Defining mechanisms of immunotherapy resistance and targeting TIGIT in hepatobiliary cancers

Project Summary/Abstract
Advanced stage hepatobiliary cancers, including hepatocellular carcinoma (HCC) and biliary tract cancers
(BTC), are often rapidly fatal diseases due to a lack of effective systemic treatments for most patients. While
anti-PD-1/L1 therapies have emerged as frontline treatments for hepatobiliary cancers, they only induce
responses in a minority of patients. Identifying and thwarting resistance mechanisms to anti-PD-1/L1 therapies
in hepatobiliary cancers is critical to expanding the effectiveness of immunotherapies in these diseases. T cell
immunoglobulin and ITIM domain (TIGIT) is an inhibitory receptor expressed on lymphocytes and NK cells, and
is a candidate compensatory immune checkpoint which may mediate anti-PD-1/L1 treatment resistance in
hepatobiliary cancers. This proposal presents a five-year research career development program encompassing
the study of an anti-TIGIT antibody as a novel treatment in refractory hepatobiliary cancers and training
objectives that will enable the applicant to independently lead clinical trial investigations, learn new technologies
and computational methods using spatial and single-cell data, and gain an expertise in tumor immunology. The
central hypothesis is that concomitant blockade of TIGIT and PD-1 will induce robust anti-tumor immunity against
HCCs and BTCs. This hypothesis will be tested in the following aims: Aim 1) Conduct a phase 2 trial of an anti-
TIGIT plus anti-PD-1 antibody regimen in hepatobiliary cancers refractory to PD-1 blockade. Aim 2) Characterize
immune and molecular features of anti-PD-1/L1 therapy refractory tumors and identify markers of resistance or
response to TIGIT blockade. Aim 3) Assess dynamics in circulating tumor DNA (ctDNA) to define genetic markers
of anti-PD-1 and/or anti-TIGIT therapy resistance and evaluate its use as a non-invasive pharmacodynamic
marker. These studies have the potential to expand the treatment armamentarium against hepatobiliary cancers,
and uncover mechanisms of anti-PD-1/L1 or anti-TIGIT therapy resistance through systematic investigations of
longitudinally collected tissue and blood specimens. The long-term goal of the applicant is to become a leader
in clinical investigations of novel immunotherapies in hepatobiliary cancers integrated with in-depth and
systematic studies to elucidate mechanisms of response and resistance. The proposed study will be conducted
under the mentorship of Dr. David Gerber, a clinical trialist and translational investigator, Dr. Tao Wang, a cancer
immunologist and computational scientist, and Dr. Hao Zhu, a translational scientist in the fields of liver
regeneration and tumorigenesis. In addition to the candidate’s passion for science, the enthusiastic support of
his experienced mentors, and the breadth of resources and expertise at UT Southwestern, this award will enable
the applicant to transition into an independent investigator and generate new hypotheses or treatment
approaches to improve the lives of patients with hepatobiliary cancers.

Public health relevance
Project Narrative Hepatobiliary cancers, including hepatocellular carcinomas and biliary tract cancers, are the fourth most frequent cause of cancer-related deaths worldwide and have an increasing disease incidence in the US and globally. Immunotherapies are only effective in a minority of patients with hepatobiliary cancers, indicating that a better understanding of resistance mechanisms and improved treatment strategies are needed. This proposal will test the effects of a novel combination of immunotherapies in patients with hepatobiliary cancers that have progressed on prior treatments, and profile longitudinally collected tissue and blood specimens from patients receiving immunotherapy to uncover predictors and mechanisms of drug resistance or response.